A Virtual Center for Collaborative Research in Complementary and Integrative Health Institutions

PROJECT SUMMARY / ABSTRACT
CIH institutions often lack the essential research resources and critical infrastructure necessary to support
clinical research, including the development of aspiring clinician-scientists. These resources include
administrative support, training in research design and grants administration, access to specialized
methodologic cores, and the ability to facilitate interdisciplinary partnerships. The University of Pittsburgh
(Pitt) is uniquely positioned to address this critical gap by providing these and other key resources through
ENcouraging Research In Complementary and integrative Health institutions (ENRICH), a REACH Virtual
Resource Center. Housed at Pitt’s Institute for Clinical Research Education (ICRE), ENRICH will offer
individualized resources and support to CIH institutions. It will leverage the ICRE’s array of innovative,
asynchronous, online educational modules on topics pertinent to clinical trials and research in CIH, as well as
its hands-on training opportunities in grant writing, to enhance the career development and productivity of
aspiring clinician-scientists. The ICRE’s resources will be further strengthened by mentorship from
experienced researchers at Pitt’s School of Health and Rehabilitation Sciences (SHRS), which has a record of
successful collaboration with CIH institutions. Our team of experienced investigators with CIH expertise has a
proven record of working with under-resourced institutions. Through ENRICH, we will create a virtual
scientific hub of research resources for CIH institutions, facilitate multidisciplinary research through an online
collaboratory, and provide pilot funding for clinician-scientists to execute their research.
Our Specific Aims are: 1) Strengthen the research environment at CIH institutions through targeted support
for administrative staff; 2) Provide mentorship, research training, and grantsmanship support to clinician-
scientists from partnering CIH institutions to increase the quality and quantity of their grant applications; 3)
Foster multi- and interdisciplinary research partnerships across partnering CIH institutions through the
creation of a virtual collaboratory and an annual virtual summit; and 4) Provide opportunities for CIH
clinician-scientists to cultivate expertise in designing and implementing rigorous scientific studies and to
obtain pilot funding to generate preliminary data for future NIH grants. By leveraging Pitt’s comprehensive
resources and rich network of mentors in CIH, ENRICH will address a key unmet need, enabling CIH
institutions to improve their research infrastructure and providing a pathway to build the next generation of
CIH clinician-scientists' research careers. This study is responsive to RFA-AT-23-009 and aligns with the
NCCIH’s key strategic goals of supporting the research training and career development of CIH clinician-
scientists and fostering interdisciplinary collaborations.

Public health relevance
PROJECT NARRATIVE This project will enhance the research capacity of Complementary and Integrative Health (CIH) institutions by providing essential resources, training, and mentorship through the ENRICH Virtual Resource Center. By supporting clinician-scientists and research professionals in these institutions, ENRICH will enhance their ability to conduct high-quality research and secure funding, thereby advancing the field of integrative health. This initiative aligns with the National Center for Complementary and Integrative Health's goals to advance the quality and impact of CIH research, ultimately benefiting public health by improving the evidence base for integrative health practices.